UOFL ENVIRONMENTAL HEALTH SCIENCES TRAINING PROGRAM

ABSTRACT
We have made strategic changes in our environmental health sciences training program in response to the
announced restructuring and redirection of NIEHS training programs. Participating Centers, Institutes, and
Schools and the members of the training faculty provide critical resources for cutting edge basic science, clinical
research, computational sciences and public health. Environmental health science partnerships have resulted in
a very successful NIEHS training program in environmental health sciences. Our renewal proposal incorporates
and integrates several Schools, Centers, and Institutes, including the new Envirome Institute, the recently funded
NIEHS P42 Superfund Research Program and the soon to be funded NIEHS P30 Core Center in Environmental
Health Sciences. We propose a substantially improved predoctoral and postdoctoral training program that serves
as an umbrella for interdisciplinary and integrated approaches to environmental health sciences. The training
program will support six predoctoral and three postdoctoral trainees. Initial student recruitment and funding for
predoctoral trainees is provided by the University of Louisville Integrated Programs in the Biomedical Sciences
recruitment gateway. As in the previous cycle, predoctoral trainees will not be recruited directly into the
environmental health sciences training program. All faculty mentors are asked to nominate trainees who have
completed an approved dissertation proposal with a defined focus in environmental health sciences research.
Faculty mentors will be asked to nominate either existing postdoctoral fellows or from trainees to be recruited.
Teams of mentors (basic and clinical scientists or basic and population-based scientists) will be particularly
encouraged to emphasize the importance of multidisciplinary training and translation of basic science findings to
the patient and/or community. Our training program facilitates multidisciplinary approaches for effective
intervention and interfaces exceptionally well with the NIH Roadmap as well as with the strategic plans of NIEHS
and the University of Louisville.

Public health relevance
PROJECT NARRATIVE The environmental health problems faced by the nation are multi-factorial in nature, and therefore require multi-disciplinary approaches for effective intervention. Our training program emphasizes the importance of multidisciplinary training and translation of basic science findings to obtain rigorous, reproducible and transparent results that benefit the patient and/or community. This multi-disciplinary translational program interfaces with the NIH Roadmap and the NIEHS strategic plan.